NIH Support for Conferences and Scientific Meetings

Project Abstract
This conference grant will support the annual conference for the American Academy of Addiction
Psychiatry (AAAP). The annual AAAP Annual Meeting and Scientific Symposium provides a
unique forum for dissemination of scientific information to psychiatrists, physicians and other
practicing clinicians in the addictions field. Because of the small size and intimate nature of the
meeting, it provides an ideal setting for networking, mentoring and informal interactions for all
attendees, offering a specific focus on trainees in the field. This grant has been incredibly
important in getting young clinical researchers interested in the field.

Public health relevance
Project Narrative 2018 - 2022 The American Academy of Addiction Psychiatry's (AAAP) Annual Meeting and Scientific Symposium provides a unique forum for disseminating state-of-the-art information to physicians and other health professionals in the field of substance use disorders and co- occurring medical and psychiatric disorders. AAAP's educational objectives are to: 1) recognize emerging issues and trends in Addiction Psychiatry and be on the forefront of diagnosis and treatment of substance use disorders (SUD) and co-occurring mental disorders. 2) Provide support and education to Addiction Psychiatrists and clinicians treating patients with substance use disorders. 3) Demonstrate for trainees the various evidence- based approaches, treatments, and settings applicable to the field (or practice) of Addiction Psychiatry. With nearly 750 participants last year, the meeting provides an ideal setting for networking, mentoring and cultivating collaborative efforts. The meeting is designed to present the latest findings from basic and clinical research as well as innovations in training and education in the field of addictions. While a focal point of the meeting is dissemination of information through a variety of mechanisms (symposia, medical update, workshops, case conferences, papers, posters and maintenance of certification activities, etc.), the meeting also provides the organizational backdrop for the exchange of ideas, discussions and working groups focused on other AAAP educational, training and policy- based activities. For the past 15 years, AAAP has received support from NIDA for this meeting which has been critical to improving and expanding the meeting including: 1) conference proceedings provided via a weblink for all participants, registrants who couldn't attend and AAAP members at no charge, to be used as references for establishing clinical practice and promoting research, 2) Support for trainees to attend the annual meeting which plays a critical role in engaging early career physicians to the field, and 3) Supporting a NIDA Clinical Trials Network (CTN) symposium highlighting CTN projects that are most ready for dissemination to influence clinical practice. In particular, AAAP's CTN Symposium has been a well-attended and an important part of the Annual Meeting and we plan on continuing an annual CTN update in the future should this application be funded. Last year, the CTN symposium was also linked with an educational activity that provided ABPN approved self-assessment credits for all attendees as well. Also described in this application are plans for other symposia, workshops, and mentoring activities that will be part of the Annual Meetings during the period of support requested. AAAP's Annual Meeting and Scientific Symposia have benefited greatly from ongoing NIDA support. We hope to continue to work together with NIDA to provide state-of-the-art information about evidence-based treatments to growing number of physicians and other health-care providers who are addiction clinicians, research and educators.